Strain-Programmed Bioadhesive Patch for Enhanced Diabetic Wound Healing

ABSTRACT
The objective of this proposal is to optimize and validate the strain-programmed bioadhesive patch in compliance
with FDA regulatory guidance for the FDA IDE approval in advance of the future pivotal clinical trial and ultimate
regulatory clearance and commercialization. In light of the huge and rapidly growing clinical and economic costs
of chronic diabetic wounds and associated complications, various treatments including skin scaffolds and growth-
factor-based drugs have been proposed and clinically tested. To date, however, the existing approaches still
face several limitations for diabetic wound healing including limited therapeutic efficacy and/or high cost of
product/treatment. To address these limitations of existing solutions, during the prior development (Phase I-
equivalent), our collaborative team developed a proof-of-concept prototype of a strain-programmed bioadhesive
patch for enhanced diabetic wound healing by uniquely utilizing pro-regenerative mechanical modulation. The
preliminary pre-clinical validation and analysis based on in vivo db/db mice, diabetic porcine, and diabetic
humanized mice models revealed the promising therapeutic potential and underlying mechanisms of the strain-
programmed bioadhesive patch for the accelerated healing of diabetic cutaneous wounds. Building upon the
promising outcome of the prior development, under the scope of this Direct Phase II SBIR proposal, we will
further optimize and validate the strain-programmed bioadhesive patch in compliance with relevant FDA
regulatory guidance for the effective and broadly affordable treatment of chronic diabetic wounds such as DFU.
If successful, the proposed project will allow SanaHeal to prepare and submit the FDA IDE package in advance
to a pivotal clinical trial and ultimate commercialization with far-reaching benefits for patients and the healthcare
system.

Public health relevance
NARRATIVE Chronic diabetic wounds such as diabetic foot ulcers (DFU) are one of the major clinical complications in patients with diabetes and incur substantial and rapidly growing clinical and economic burdens in aging societies around the world. During the prior development (Phase I-equivalent), the collaborative team developed and evaluated a proof-of-concept prototype of a strain-programmed bioadhesive patch for accelerated diabetic wound healing. In the proposed project, we will continue optimization and validation of the strain-programmed patch based on pre- clinical and GLP testing in compliance with FDA regulatory guidance toward the FDA IDE approval in advance of a pivotal clinical trial for the ultimate regulatory clearance and commercialization.